ACTG 306-ANTIVIRAL ACTIVITY AND RESISTANCE INTERACTIONS OF 3TC AND ANTIHIV DRUGS

The purpose of this study is to compare the efficacy (as measured by viral load) and safety and tolerability of several anti-HIV drugs used alone or in combination in antiretroviral naive patients with 200-600 CD4.